Transforming Hospitalizations of Autistic Adolescents via a Novel ABA Telehealth Platform

You said:
Phase II TABA Research Strategy 1R44MH134706.pdf
PDF
based on the attached plan, what is a good 'Project Summary/Abstract' in the convenƟonal terminology
and length typically done for a Phase II AdministraƟve Supplement for TABA?
ChatGPT said:
ChatGPT
Here’s a convenƟonal "Project Summary/Abstract" based on the attached Phase II TABA plan:
Project Summary/Abstract
We are requesƟng Phase II Technical and Business Assistance (TABA) funding to advance the
commercializaƟon of Hospital TeleABA, an innovaƟve telehealth platiorm designed to support hospital
care for auƟsƟc children and adolescents. This funding will enable the strategic implementaƟon of our
soluƟon into hospital systems, with plans for future expansion into schools and residenƟal settings for
auƟsƟc teens and adults.
Our Phase I research demonstrated the feasibility and potenƟal of Hospital TeleABA to enhance
behavioral support for hospitalized adolescents with auƟsm. Over 109 I-Corps interviews and more than
120 stakeholder feedback sessions validated the need for our telehealth soluƟon, confirming its uƟlity in
improving behavior management and discharge planning. The prototype we developed successfully
integrated trauma-informed behavior stabilizaƟon (TIBS) protocols, and preliminary trials demonstrated
strong clinical uƟlity, with a 97% correlaƟon in behavior idenƟficaƟon between remote observers and in-
person evaluaƟons.
To ensure successful commercializaƟon, we will leverage TABA funding to access strategic guidance in
markeƟng, regulatory compliance, and reimbursement pracƟces. This will be facilitated through
partnerships with the Council of AuƟsm Service Providers (CASP) and DRA CollecƟve, Inc., who will
provide criƟcal experƟse in operaƟonal guidelines, billing pracƟces, and strategic market posiƟoning. Our
goal is to establish Hospital TeleABA as the leading telehealth platiorm for behavioral support in hospital
settings, while building the capacity to scale naƟonwide.
With TABA support, we aim to solidify our market presence ahead of clinical trials set to begin in early
2025, ensuring that our soluƟon meets the high standards of care expected in hospitals, while also
aligning with the best pracƟces established by CASP.

Public health relevance
Project Narrative AuƟsƟc children and adolescents face significant challenges during hospitalizaƟons, often requiring specialized behavioral support to manage crises and improve outcomes. Our Hospital TeleABA platiorm addresses these challenges by offering a telehealth soluƟon designed to enhance behavior management and discharge planning in hospital settings. Through trauma-informed behavior stabilizaƟon (TIBS) protocols and AI-supported systems, Hospital TeleABA supports hospital staff in managing behavioral crises for auƟsƟc paƟents, thereby reducing the risk of trauma and improving care outcomes. With the support of Phase II TABA funding, we will focus on the commercializaƟon of Hospital TeleABA. This includes developing a strategic plan to integrate the platiorm into hospital systems naƟonwide, ensuring regulatory compliance, opƟmizing billing pracƟces, and posiƟoning the platiorm as a leader in the telehealth space for auƟsm care. Our goal is to provide hospitals with the tools to deliver better, more reliable behavioral support for auƟsƟc children and adolescents, ulƟmately leading to shorter hospital stays, reduced costs, and improved outcomes for both paƟents and caregivers. By making Hospital TeleABA available in hospitals across the U.S., we aim to transform the standard of care for hospitalized auƟsƟc paƟents and ensure that these children receive the high-quality, specialized care they need.